DUCTUS ARTERIOSUS STENT TO IMPROVE CONGENITAL HEART DEFECT MORTALITY

ABSTRACT
The technical challenges faced by pediatric cardiovascular physicians (surgeons and interventionalists alike)
have long been ignored, forcing them to use devices designed for adults and different conditions to treat ailing
babies with very specific anatomical considerations. One such case is in the sustained opening of the ductus
arteriosus, a natural conduit that exists in all newborns but closes shortly after birth. In certain congenital heart
defects, it is crucial to maintain ductus patency for the newborn to survive without surgical intervention. There is
no ductus arteriosus stent commercially available in the US. Pediatric interventional cardiologists currently
repurpose adult stents for the ductus, and all-cause ductus reintervention is 47%. The alternative is open-chest
surgery on a neonate to place a shunt that carries a 13.1% risk of morbidity and 7.2% risk of mortality in the US.
Starlight Cardiovascular proposes creating and commercializing the first FDA-approved ductus arteriosus stent
that is specifically designed to address the challenges facing treating physicians, including a right-sized delivery
system, end-to-end coverage of the ductus, navigation and deployment through tortuous ductus anatomy, and
precise placement to avoid stent protrusion into the aorta and pulmonary arteries. A stent designed and tested
specifically for this purpose has the potential to decrease reinterventions, morbidity, and potentially mortality for
babies with ductal-dependent circulation. The feasibility of the innovative stent system designed for pediatric
applications using self-expanding technology was demonstrated in a successful Phase I through numerous
rounds of bench testing, physician evaluations, and an animal study; and this Phase II application proposes
finalizing the stent design and completing preclinical testing necessary for a clinical trial and FDA approval.
Through rapid iterations, Starlight will begin by optimizing the stent system for design characteristics and
manufacturability. Starlight will then complete a chronic GLP animal study in 16 newborn lambs to demonstrate
stent patency over 180 days. Verification and validation (V&V) testing of all aspects of the stent system (including
biocompatibility, sterilization, and mechanical testing) will then be performed in accordance with FDA guidance
documents for endovascular stents. This Phase II project will result in a finalized ductus arteriosus stent system
design that has passed all of the necessary preclinical testing required for a clinical trial and subsequent FDA
approval through the Humanitarian Device Exemption pathway.

Public health relevance
PROJECT NARRATIVE One percent of babies are born each year with Congenital Heart Disease (CHD), and these babies often require surgical intervention to survive. However, the devices that are currently used to treat this pediatric population were designed for adult cardiovascular conditions and do not always perform as intended in babies. Starlight Cardiovascular aims to solve this problem by developing a portfolio of devices for CHD, starting with what will be the first FDA-approved ductus arteriosus stent, which as the potential to save lives and increase access to less invasive treatments for babies born with CHD.